NATIONAL ADDICTION AND HIV DATA ARCHIVE PROGRAM. APRIL 1, 2019 - MARCH 31, 2020. N01DA-19-5587.

The objectives of this contract are to continue a data archive of drug abuse and drug abuse and HIV research data, primarily archiving social science and behavioral data though other data could be included.